COORDINATED FACILITIES REQUIREMENTS FOR FY25 - FACILITIES TO I

The NCI Frederick Building Automation System (BAS) is a complex network of computers which control and monitor nearly all the NCI Frederick building systems, including air handlers, exhaust systems, chillers and heating systems. Failure of a component of the BAS can result in the failure of one of these critical building systems with subsequent impact to scientific research or animal health. Many of the BAS controllers are the original version, Micro-Smart Controllers (MSC) from the late 1990’s and early 2000’s. Advancements in technology have made the MSC system obsolete and antiquated. Replacement parts for the MSC system are no longer available nor is the software supported. Hardware is unavailable, creating risks to the BAS and the building systems it controls.

The first three phases of the upgrades to the campus BAS are now complete. Phase 4 will be completed in October 2025:

• Phase 1: Complete: Phase 1 replaced the antiquated MSC controllers at the highest risk buildings; animal buildings and freezer repositories.
• Phase 2: Complete: Replace obsolete MSC controllers in remaining buildings that have BAS.
• Phase 3: Complete: Replace obsolete UNC controllers on campus and at the ATRF.
• Phase 4: Provide labor, material, new BAS controllers and programming necessary for each monitoring/control point(s) in each building listed below to report to the campus Building Automation system. Each device/system shall be tested and verified.